GROWTH HORMONE RELEASING HORMONE ANTAGONIST ON GH RELEASE IN ACROMEGALY

The purpose of the study is to determine the role of endogenous growth hormone (GH)-releasing hormone (GHRH) in the regulation of nocturnal, basal and pharmacologically stimulated GH secretion in men and women. The hypotheses that GHRH secretion is age related and that GH hypersecretion in acromegaly is driven by hypothalamic GHRH are also being investigated.